VIROLOGIC RESPONSE TO NEW NUCLEOSIDE REGIMENS AFTER PROLONGED ZDV OR DDI IN HIV

ACTG 302 - The purpose of the study is to determine the influence of HIV virius load, characteristics of the virus and the presence of symptoms on response to new therapeutic regimens and on the development of ciral resistance mutation in HIV infected individuals who have been treated with monotherapy with either ZDV or ddI on a previous ACTG trial (ACTG 175). More specifically, this study will determine whether the addition of 3TC or a change to d4T in patients who have been ZDV result in a more rapid or durable suppression of plasma viral RNA.